Image-Guided Workstation and Tools for Bone Defects

Summary
Our long range goal is to develop an image-guided workstation that uses a novel Continuum Dexterous
Manipulator (CDM) and tools to enable next generation of minimally- and less-invasive procedures allowing
access to regions not currently accessible with conventional surgical tools in orthopaedic surgery. The system
and devices will enable treatment of bone defects such as femoroacetabular impingement, metastatic bone
disease, severe osteoporosis in areas including the pelvis/acetabulum, femoral neck, peri- and sub-
trochanteric regions, as well as the shin and foot, and finally traumatic fracture repair. The near-term focus of
this application is the core decompression for the treatment of Avascular Necrosis (AVN) of the femoral head
and reduction of pelvis fracture. We propose the development of an image-guided prototype robot-assisted
surgical system for planning, real-time intraoperative monitoring, navigation, and updating of the plans.
In the United States, avascular necrosis (AVN, also known as osteonecrosis) of the femoral head occurs in
10000-20000 of patients per year between the ages of 20-50 years old. The incidence of the AVN is even
higher in Middle Eastern and Asian countries. AVN occurs due to the loss of blood supply to the bone, leading
to the spontaneous death of the trabecular bone, which in turn may cause microfractures in the trabecular
bone. Depending on the amount of femoral head involved, collapse of the articular surface will occur as the
disease advances. Once collapse of the femoral head occurs in these patients, the disease course rarely
regresses. Total Hip Arthroplasty (THA) will be the primary surgery of choice and will provide pain relief to
those AVN patients. However, because of the young age of the AVN patients, THA is not the most desirable
choice. Core decompression is a conventional techniques used for the treatment of the AVN prior to the
collapse of the femoral head. Typically in core decompression the lesion area (death bone) is removed by
drilling and debriding. After debriding the bone graft will be inserted and/or bioresorbable material such as
calcium phosphates will be injected into the core to fill the void and provide stability.
The long-term success of core decompression is dependent on many parameters that may be out of the
control of surgeons given the existing tools and techniques. Some of the issues that the current conventional
techniques for core decompression does not answer are: 1) complete debriding of the death bone requires
significant increase in dexterity of the debriding tools, currently not available to the surgeons; 2) While it is ideal
to completely remove the death bone, the extent of the bone removal may be limited by the stability
requirements of the femoral head to prevent its collapse underweight bearing conditions. Biomechanical
analysis of the stability of the structure, therefore, must be important part of the planning. Further, the
successful implementation of the plan will require robot-assisted, image-guided navigation technology that, to
our knowledge, is currently not available to the surgeons.
To our knowledge, tools for biomechanical planning to maintain the stability of the hip after the surgery and
robotic platforms for minimally-invasive treatment of osteonecrosis are not developed. In particular, the design
of the manipulators for the full debriding of the AVN poses unique challenges because of the opposing
requirements for structural strength and flexibility. We propose to develop and test a prototype robot-assisted
surgical workstation for minimally-invasive treatment of the AVN. The workstation, during the planning phase,
will highlight the site of the lesion in MRI images of the patient and create an optimized surgical plan. During
the procedure, the surgeon will use a Continuum dexterous manipulator (CDM) in conjunction with a
positioning robot and various tools to remove the death bone and perform structural augmentation. Our goal is
to demonstrate that the proposed system can significantly improve the treatment of the AVN and the stability of
the hip, therefore, reducing the need for multiple follow-up surgeries and/or THA surgeries at early ages.

Public health relevance
Project Narrative If successful, the work proposed here will lead to a novel therapeutic approach for the treatment of osteonecrosis of the femoral head.